Occupational and Environmental Exposures and Work Practices for Nanomaterials and Electronic Products

PROJECT ABSTRACT
The proposed training program aims to provide professional training through academic curricula, research
experiences, and continuing education courses in industrial hygiene and environmental health sciences to
graduate students and industrial hygienists in the Southern California region, and to recruit diverse
undergraduate and graduate students to join the graduate school pursuing master and doctoral studies in
occupational and environmental health sciences related fields. The Southern California Superfund Research
Program (SCSRP) will build on the strong educational and research environments at the University of California
Los Angeles (UCLA) and the well-established UCLA Industrial Hygiene and Environmental Health and Sciences
(EHS) programs to develop a modern and multidisciplinary training program for students and the community of
industrial hygienists. Our mission is to prepare next-generation professionals for effective management of
stressors caused by emerging technologies such as nanotechnology. Our multidisciplinary team includes the
highly diverse faculty members and student population at UCLA, UC Irvine (UCI) and California State University
Fullerton (CSUF) and Long Beach (CSULB). Our faculty team has a proven track record in mentoring students
with a combined total of more than 350 trained graduate and undergraduate students and postdoctoral fellows.
Our team consists of industrial hygienists, environmental scientists, population health experts and community
partners. Our training will focus on occupational exposures and effects, digital learning techniques, practices and
protection guidance regarding engineered nanomaterials, emerging infectious agents, and nanotechnology-
enabled products including consumer electronic products and their related waste to be managed at the
generation and disposal stages. It is essential to provide proper training on the hazards of exposure to new
materials used in emerging and rapidly changing technologies and their effective control strategies for workers,
industrial hygienists, and the students, who will make up the future workforce. Our program broadens the scope
of current educational approaches with new and unique training regarding emerging technologies which are
unavailable in our other existing training programs. We anticipate training 6, 7 and 8 graduate students in years
1, 2, and 3-5 respectively. This includes 2-3 nine-month trainees and 4-5 summer trainees per year. We also will
recruit a diverse population of undergraduate students, with openings to 4-5 students per year with the 5-day
training workshop. During the five-year program period, we anticipate providing 37 training positions for master
and doctoral students; and for undergraduate students, providing them with 24 training opportunities in the 5-
day workshop in the hopes of future recruitment into graduate school. We will also train more than 100 industrial
hygiene professionals through the continuing education courses. Upon completion of our program, participants
will be well-trained industrial hygienists influential in the next generation workforce. These outcomes will aid the
expansion of the existing educational programs in industrial hygiene and environmental health sciences.

Public health relevance
PROJECT NARRATIVE The Southern California Superfund Research Program (SCSRP) will develop a modern and multidisciplinary training program for students and the community of industrial hygienists, and to prepare next-generation professionals for effective management of stressors caused by emerging technologies such as nanotechnology.